Refinement and Testing of Implementation Strategies to Promote Psychotherapy Attendance for Depression among Latinx Teens

PROJECT SUMMARY/ABSTRACT
Despite experiencing a higher prevalence of depressive symptoms, Latinx adolescents are significantly less
likely to receive treatment for Major Depressive Disorder (MDD) and are more likely to drop out of
psychotherapy prematurely than their non-Latinx White peers. Research is needed to develop patient- and
family-focused implementation strategies to promote Latinx adolescents' initiation of and retention in
psychotherapy for depression. The candidate aims to identify, refine, and test a patient- and family-focused
implementation strategy to target barriers to psychotherapy attendance among Latinx youth. In Aim 1, a
national sample of Latino adolescents (n=15), parents (n=15), and healthcare providers (n=5) will participate in
focus groups to identify preferred strategies to promote psychotherapy attendance. In Aim 2, a series of design
thinking workshops will be carried out with a community advisory board (N=8) to refine and develop the content
of the implementation strategy. Qualitative descriptive methods and rapid content analysis will be employed in
aims 1 and 2. In Aim 3, the candidate will conduct a clinical trial to determine the preliminary effect of the
patient- and family-focused implementation strategy on psychotherapy attendance and depressive symptoms
among Latinx adolescents (N=60) and identify facilitators, barriers, and early implementation outcomes
(acceptability, adoption, feasibility, and fidelity) related to the implementation of the strategy and psychotherapy
among Latinx adolescents. Latinx adolescents diagnosed with MDD or Persistent Depressive Disorder and
referred to psychotherapy will be recruited from primary care clinics in North Carolina and randomly assigned
to the implementation strategy or treatment as usual group (n=30 each). Measurements will be taken at
baseline, 12 weeks, and 24 weeks. Wilcoxon Two-Sample Tests will be used to compare group differences in
the percent of scheduled psychotherapy visits attended at 24 weeks. Wilcoxon Signed Rank Tests will be used
to determine change in the depressive symptoms from baseline to week 12, and baseline to week 24.
Qualitative interviews with Latinx adolescents, parents, and healthcare providers will be conducted to complete
a multi-method evaluation of implementation process outcomes. The results of the study will lay a foundation
for a full-scale R01 randomized controlled trial. The identified patient- and family-focused implementation
strategy might also serve as a model for addressing behavioral health disparities among other groups of ethnic
minority and immigrant youth. During this award, the candidate will also obtain critical training in
implementation science, adaptation of programs for Latinx families, adolescent depression treatment, and
clinical trial design. The proposed award will support the candidate's long-term goal of promoting mental health
equity among Latinx adolescents and her transition into an independent, health disparities researcher.

Public health relevance
PROJECT NARRATIVE Latinx adolescents experience a higher prevalence of depressive symptoms and are less likely to receive treatment for depression than their non-Latinx White peers. Evidence-based treatments for adolescent depression exist, but Latinx adolescents face both universal and culture-specific barriers to receiving these treatments. The proposed study seeks to develop and test culturally-sensitive patient- and family-focused implementation strategies that will improve initiation of and retention in evidence-based psychotherapy for depression among Latinx adolescents.